Forces Driving Membrane Protein Folds

Project Summary
Understanding how proteins fold is a central quest in biology. Studied for over 50
years, investigations of soluble protein folding have proven invaluable for dissecting the
molecular basis of a multitude of diseases. By comparison, folding studies of membrane
proteins lag far behind. The knowledge gained from soluble protein studies cannot simply
be transferred to inferences about because their solvents are different. The balance of
forces encoding a MP embedded in a lipid bilayer must be distinct from that of soluble
proteins in water.
Our research efforts contribute to filling this key gap in the understanding the physical
chemistry of membrane proteins. We will experimentally determine of energetic forces
stabilizing membrane proteins along the steeply changing polarity gradient of the
phospholipid bilayer interface, quantify backbone hydrogen bond strengths, and expand
our repertoire of membrane protein folding models to include those with an a-helical
secondary structure. These efforts will be complemented by molecular simulations and
other solution biophysics interrogations as needed.
Our results have broad ranging impact in the field at large through contributions to
information databases used in training computational algorithms and by their
incorporation in physically realistic mechanisms for protein folding catalysis by cellular
machines.

Public health relevance
Project Narrative: This discovery project will discover the physical forces dictating the native conformations of membrane proteins and their interactions with lipid bilayers. The knowledge gained from this research will contribute to the mechanisms of protein misfolding diseases, enable the rational design of therapeutics to modulate protein conformations, will be useful in the computational modeling of protein structures, and provides a biophysical and chemical basis for the design of proteins with novel functions.